Dysregulation of Cav1.2 by beta amyloid peptide

Abstract
Dysregulation of Cav1.2 by beta amyloid peptide
L-type Ca2+ channels (LTCC) are key regulators of gene transcription, neuronal excitability, and synaptic
functions. Cav1.2 is the prevalent LTCC in brain (Hell et al., 1993, JCB 123, 949-962). Chronically increased
Ca2+ influx via LTCCs has been implicated early on in senile symptoms and Alzheimer’s disease (AD) (e.g.,
Science 272, 1017). We found that aged rats have significantly increased PKA-mediated phosphorylation of
Cav1.2 on Serine 1928 (Davare and Hell, 2003, PNAS 100, 16018-23), which increases Cav1.2 channel activity
(Qian, …, Hell, 2017, Sci Sig 10, eaaf9659). We also found that Cav1.2 forms a unique signaling complex with
the b2 adrenergic receptor (b2 AR) that also contains all other proteins necessary for the cAMP-mediated
regulation of Cav1.2 (e.g., Davare et al., 2001, Science 293, 98), making Cav1.2 a prime target for b2 AR signaling.
b amyloid peptide 1-42 (Ab) is a hallmark of AD. Oligomeric Abo stimulates the b2 AR. Supportive evidence from
single channel recording indicates that Abo increase Cav1.2 activity via the b2 AR. We hypothesize that this
increase is mediated by phosphorylation of S1928, the main PKA site of Cav1.2, and triggers downstream events
that ultimately cause neuronal damage. Aim 1 is to test whether Cav1.2 dysregulation by Abo via Cav1.2-
associated b2 AR occurs in dendrites and spines (Ca2+ imaging), whether it is in part mediated by increased
surface insertion of Cav1.2, and whether blocking this signaling pharmacologically or in innovative S1928A
knock-in (KI) mice alleviates Abo neurotoxicity. Aim 2 is to test whether Abo - b2 AR - S1928 signaling stimulates
surface insertion of Ca2+ permeable (CP) AMPARs (GluA1 homomers) and blocking CP-AMPARs alleviates Abo
neurotoxicity. We will use cutting edge live imaging of SEP-tagged GluA1 and GluA2 and analyze field EPSPs
and mEPSC before and after inhibition of glutamate re-uptake to measure AMPAR activity in the perisynaptic
space. Aim 3 will test the role of Abo - b2 AR - S1928 signaling in augmentation of long-term depression by Abo,
and in long-term potentiation, which is impaired by Abo. Crossing our S1928A KI mice with highly amyloidogenic
5xFAD mice will show whether Abo - b2 AR - S1928 signaling is important for Ab-induced dysfunction of Cav1.2
activity and synaptic transmission and its plasticity. This project is focused on what we hypothesize is an early
effect of Abo (minute range) that triggers subsequent neurotoxic events because we need to understand all
aspects of Abo toxicity. Also, as an early event the Abo - b2 AR - S1928 signaling constitutes a potential target
for early pharmacological intervention in AD. We will to some degree explore later events downstream of Cav1.2
dysregulation by testing whether neurotoxicity in the 6-48h range can be improved by blockers of Abo - b2AR -
CaV1.2 signaling and of CP-AMPAR in neuronal cultures. We will also explore whether blocking this signaling in
the 5xFAD mouse model of AD will improve synapse function in these mice. The development of our peptide
that disrupts binding of the b2 AR to Cav1.2 is highly innovative because it allows to specifically block signaling
by Abo via the b2 AR without affecting other signaling pathways that involve the b2 AR.

Public health relevance
Project Narrative Dysregulation of Cav1.2 by beta amyloid peptide The L-type Ca2+ channel Cav1.2 constitutes one of the most important influx pathways for Ca2+ into neurons. Ca2+ in turn is a potent regulator of neuronal excitability and gene expression. We recently discovered that the b amyloid peptide 1-42 (Ab), which is the hallmark of Alzheimer’s disease (AD), strongly stimulates Ca2+ influx via Cav1.2. Excessive Ca2+ influx than can cause neuronal damage leading to loss of neurons and has been implicated in the etilogy of senile symptoms and AD. We will define how Ab upregulates Cav1.2 activity and subsequent downstream events affecting synaptic function to better understand how upregulation of Cav1.2 activity by Ab contributes to AD.